RAT KIDNEY CONTRAST CLEARANCE MICROSCOPY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. 1) Learn how to perform MR scans initially on a 7T system. The routine steps of MR scanning will be familiarized, including: selecting coil and phantom, connecting RF transmit/receiver, setting up convert/attenuator, scanning and acquiring data, reconstructing, and analyzing MR images. 2) Observe the clearance of the Magnevist contrast in the rat kidney system. The cortical, outer medullary, and inner medullary regions will be analyzed to determine specific clearance rates in each region. The contrast clearance rates will then be correlated with the flow rate (e.g. glomerular filtration rate). 3) Determine which pulse sequence is best for this application including SPGR, Fast GRE/SPGR, keyhole radial, Flair, and Spiral PSD.